Opioids in Cancer Pain & Drug Abuse: Optimizing Therapy

Use continuation pages as needed to provide the required information in the format shown below. Start with Principal Investigator. List all other key personnel in alphabetical order, last name first. Name Organization Role on